American Society for Intercellular Communication (ASIC)

Summary:
The American Society for Intercellular Communication (ASIC) was created by principal investigators
from the United States and Canada with a goal of creating a home for research encompassing emerging
mediators and pathways of intercellular communication (IC) beyond the scope of the existing societies.
Organizers have focused on regular yearly meetings with interest in extracellular vesicles, particles, and
RNA (EV/EP/ExRNA) and other complex pathways of molecular exchange. We believe that having
ASIC as a reputable organization in North America is significant since it will provide an intellectual home
for young scientists who are interested in basic science and bench to bedside related EV and non-EV
research. The location of the meeting (Bolger Center; Potomac, MD) provides a platform that allows
direct communication between PIs and program officers from government agencies with interest in EV
research including NIH, NIST, FDA, and NSF. The meeting and the Society are innovative in many ways
including that the meeting topics cover a broad range of IC processes far beyond the focus of existing
societies that have been largely dominated by exosome-related research. In contrast, ASIC opens the door
for studies on all supramolecular pathways of communications including EV/EP/ExRNAs, intercellular
synapses, nano- and microtubes and other mechanisms. In addition, the relatively low cost of the meeting,
which includes registrations, meals, and hotel, enables more students, postdocs, and junior faculty to
attend. In order to further promote the inclusion of Under Represented Minorities (URM) and reduce the
impact of gender or other bias, ASIC has formed the Diversity and Inclusion ASIC Committee (DIAC)
under the leadership of Dr. Julie Saugstad. Along these lines our Aims focus on bringing together
investigators from diverse basic science and clinical fields to discuss and advance understanding of the
multifactorial impact of EV/EP/ExRNA in diagnostics, treatments, and a basic understanding of the
biogenesis of normal vs. diseases states; engage young new investigators in the field of EV/EP/ExRNA
and their advancement in becoming independent successful colleagues, and bring together interested
parties to discuss relevant key significant topics regarding IC, and disseminate information presented at
the conference to the scientific community-at-large as well as to health care providers and the general
public.

Public health relevance
Project narrative: The American Society for Intercellular Communication (ASIC) is created by principal investigators from the United States and Canada with a goal of creating a home for research encompassing emerging mediators and pathways of intercellular communication (IC) beyond the scope of the existing societies.